LARGE SCALE T CELL EPITOPE DISCOVERY - COVID Supplement

The SARS-CoV-2 epitope Megapools (SARS-CoV-2 MPs) is used to study SARS-CoV-2 CD4 and CD8 specific T cell responses. The Megapool (MP) approach allows simultaneous testing of large number of epitopes. According to this approach large numbers of different epitopes are solubilized, pooled and re-lyophilized to avoid cell toxicity problems associated with high concentrations of DMSO typically encountered when single pre-solubilized epitopes are pooled. These MPs have been used for both CD4 and CD8 T cell epitope identification.